Bioinformatics Core

PROJECT SUMMARY/ABSTRACT – CORE D
The purpose of the Bioinformatics Core is to support the research projects in the analysis, management,
and synthesis of large scale and heterogeneous datasets. Data will come from a variety of sources
including microbiome amplicon and genome sequencing, plasma RNAseq, metabolomics, and from
individuals of mice and patients in clinical trials. By centralizing the development, maintenance, and
implementation of bioinformatics tools, and providing an efficient framework for synthesizing data, this
core will provide state-of-the-art bioinformatics capabilities that are responsive and tailored to user’s
needs and ensure data compatibility and comparability within and across projects. The Bioinformatics
Core has the following specific aims, each involving direct interactions with the research projects and
other cores: (1) Develop, maintain, and implement bioinformatic pipelines for analysis of genomic and
transcriptomic data from microbiomes and their hosts. This aim is crucial for supporting the research
project aims that are focused on understanding how changes in the microbiome composition and
metabolism are linked to metabolites, immune responses, and health outcomes. Bioinformatics Core staff
and students will work directly with students, postdocs, and staff from each of the research projects (see
Aim 2) to understand their scientific goals and develop bioinformatics solutions. (2) Train scientists in
bioinformatics and foster communication between scientists and bioinformaticians. Bioinformatics staff
and students will train students, postdocs, and staff from each of the research projects in both the
conceptual understanding the technical implementation of the various tools. (3) Synthesize the diverse
data streams with a database that is flexible for adaptation and enables user-friendly data queries and
modeling to address research questions and aims of the projects. This specific aim addresses the
challenge of analyzing and synthesizing enormous quantities of data that is highly complex and inter-
connected, diverse in form, and multi-dimensional. This database will enable researchers to efficiently
interrogate the data and export it into various formats for downstream purposes. The Bioinformatics Core
will be directed by Dr. Gregory Dick.